Systematic dissection of function and mechanism of long non-coding RNAs in glioblastoma

PROJECT SUMMARY/ABSTRACT
Glioblastoma (GBM), a high-grade glioma (grade IV), is the most prevalent and malignant primary brain tumor
in adults. There is no effective treatment of GBM. After standard treatment, the median survival of GBM
patients is around 15 months. GBM is featured by enhanced cell proliferation, high propensity of
invasion/diffuse infiltration throughout the brain, and resistance to chemo-/radiation therapy. Emerging
evidence supports that long non-coding RNAs (lncRNAs, ~18,000 human lncRNA genes) can mediate tumor-
promoting/suppressing effects and serve as independent diagnostic/prognostic biomarkers. Our previous
integrative genomic study revealed that many lncRNAs show dysregulated expression, are associated with
clinical prognosis, or harbor frequent somatic copy number alterations in GBM, suggesting an important role of
lncRNAs in GBM pathogenesis. However, the function and mechanism of most lncRNAs in GBM are unknown.
To fill this gap, our long-term goal is to leverage systematic multi-omic approaches to characterize the function
and mechanism of lncRNAs in GBM, and to help develop new therapeutic strategies based on novel insight
into lncRNA regulation in GBM. Our large-scale loss-of-function screen using CRISPR interference (CRISPRi)
identified an antisense lncRNA, lnc-YINC (YBX1-interacting lncRNA) that was critical for GBM cell growth and
was significantly up-regulated in GBM compared with normal brain tissue and low-grade glioma (LGG). The
higher expression of lnc-YINC was associated with shorter overall survival of GBM patients. Functionally, lnc-
YINC acted in-trans and was a key regulator of cell cycle progression of GBM cells/glioma stem cells (GSCs)
and self-renewal of GSCs. It also protected GBM cells/GSCs from DNA double-strand breaks (DSBs) caused
by endogenous stress or exogenous ionizing radiation. Mechanistically, lnc-YINC interacted with YBX1, and
post-transcriptionally regulated the expression of key regulators of cell cycle or DSB repair, at least partially by
stabilizing their mRNAs. Based on these new findings, we hypothesize that lnc-YINC is a GBM-promoting
lncRNA that promotes proliferation of and modulates radio-sensitivity of GBM cells/GSCs, by enhancing YBX1
binding to key regulators of cell cycle/DSB repair and co-regulating their expression at post-transcriptional level.
The objectives of this proposal are (a) to determine the role of lnc-YINC in gliomagenesis, (b) to integrate
enhanced CLIP-seq (eCLIP-seq), ribosome profiling, RNA-seq and quantitative mass spectrometry data, with
functional assays to identify the downstream targets of lnc-YINC/YBX1 that are key to regulating cell cycle or
DSB repair, (c) to dissect the molecular mechanisms whereby lnc-YINC/YBX1 axis post-transcriptionally
regulates the expression of key regulators of cell cycle or DSB repair, (d) to determine the role of lnc-YINC in
modulating radio-sensitivity of GBM cells/GSCs and to investigate the therapeutic impact of combining
inhibition of lnc-YINC with radiation therapy on GBM maintenance in vivo. This application is strengthened by a
team of experts of basic/clinical science of GBM, DNA damage repair, RNA biology and proteomics.

Public health relevance
Public Health Relevance Statement: Glioblastoma (GBM) is the most prevalent and malignant primary brain tumor in adults, with a median patient survival of about 15 months after standard treatment. The proposed research will define the role of a novel long non-coding RNA (lncRNA) and a lncRNA/RNA-binding protein complex in promoting the cell-cycle progression and in regulating radiosensitivity of GBM cells/glioma stem cells (GSCs), and will reveal a new mechanism of its function. The proposed studies will provide new insight into how lncRNAs contribute to the molecular pathogenesis of GBM and may help develop effective therapeutic strategies to treat this devastating disease.